Leveraging mitochondrial function to combat radiation therapy-induced microvascular disease

Approximately 200,000 veterans receive cancer treatment at Veterans Health Administration facilities. With
improving survival rates for many cancers, the deleterious long-term cardiovascular side effects of cancer
therapies have become increasingly apparent. For many of the cancers that frequently occur among veterans,
radiation therapy (RT) is an integral component of treatment. Despite improvements in the techniques used to
target RT to the cancer tissue, some radiation always reaches surrounding normal tissue. Endothelial damage
within the small blood vessels or “radiation endotheliopathy” has been postulated as a major cause of RT-
induced injury of normal tissue. Many post-radiation syndromes have been attributed to radiation
endotheliopathy. One of them is cognitive decline, which is estimated to affect as many as 90% of patients
after brain RT. Mechanistically, radiation endotheliopathy is believed to be initiated by mitochondrial injury,
leading to chronic oxidative stress and endothelial dysfunction over a period of years. Thus, intervention at the
time of RT is likely critical for reducing radiation endotheliopathy and its sequelae, including cognitive decline.
The discovery of effective mitigators will require a unified view of the pathways by which RT-related
mitochondrial injury influences various steps in this progression; this has not been achieved to date.
The objective of the proposed project is to identify the mechanisms by which mitochondrial injury promotes
radiation endotheliopathy, and to test whether protection from mitochondrial injury prevents adverse short- and
long-term effects of RT in small blood vessels. RT induces mitochondrial DNA damage, perturbs ATP
production, enhances the mitochondrial membrane potential, Ca2+ uptake and reactive oxygen species (ROS)
production. The mitochondrial Ca2+ uniporter (MCU) regulates Ca2+ uptake into the mitochondrial matrix and
was recently reported as being redox-dependent. Mitochondrial Ca2+ augments ROS production that promotes
further mitochondrial dysfunction. Thus, we posit that MCU in endothelial cells (ECs) drives a feed-forward
circuit with mitochondrial ROS that leads to long-term adverse effects of RT, including cognitive decline after
brain RT. Indeed, published data from our laboratory demonstrate that blocking mitochondrial Ca2+ uptake is
sufficient to reduce mitochondrial ROS production and protect EC barrier function. Thus, our central
hypothesis is that MCU-mediated Ca2+ uptake by mitochondria is required for excessive ROS
production after RT, and thus for chronic mitochondrial DNA damage, blood brain barrier (BBB)
breakdown, capillary loss, and cognitive decline. This hypothesis is further supported by our strong pilot
data that inhibition of MCU in ECs during RT abolishes mitochondrial DNA damage in vitro and protects
against BBB breakdown in vivo. Our novel tools and assays put us in the perfect position to perform the
proposed study. These include genetic models in which mitochondrial Ca2+ uptake can be modeled selectively
in ECs, state-of-the-art radiation equipment, assays of microvessel dysfunction and behavior in vivo, and
innovative nanoparticle-based tools for selectively targeting ECs at the time of RT. Our aims are to 1. dissect
the mechanisms by which mitochondrial Ca2+ uptake drives endothelial injury by RT, 2. test whether
inhibition of mitochondrial Ca2+ uptake in ECs protects against RT-induced injury in vivo and 3.
determine the extent to which nanoparticle-mediated delivery of MCU inhibitors protects against RT-
induced EC injury.
The rationale of our proposed studies is that an improved understanding of the mechanisms of radiation
endotheliopathy will enable the development of effective therapies. Upon its successful completion, we will
have established mechanisms by which MCU promotes mitochondrial injury after radiation, and how
endothelial-selective delivery of an MCU inhibitor might be implemented as a first step towards developing
effective mitigators of radiation endotheliopathy that will benefit our veterans.

Public health relevance
Approximately 200,000 veterans receive cancer care in VHA facilities. About 30% of them undergo radiation therapy as part of their treatment. With increasing cancer survival rates, the long-term adverse side effects of cancer therapies, including radiation therapy have becoming widely apparent. Damage to endothelial cells, in particular in microvessels is believed to drive many long-term health problems after radiation therapy, including heart failure and lung fibrosis after radiation therapy to the chest and cognitive decline after radiation therapy to the brain. The proposed research aims at understanding how mitochondria in endothelial cells mediate the radiation-induced microvascular damage and provide proof of concept for developing new mechanism-based treatments. The proposed research is directly relevant to VA healthcare because of the high disease burden of cancer with its increasingly recognized implications for vascular disease and the enormous health care cost it causes in veterans.